Spatial Frequency Domain Imaging to Investigate Mechanistic Constituents in Active Thyroid Eye Disease

PROJECT SUMMARY/ABSTRACT
Thyroid Eye Disease (TED) is an inflammatory condition that can lead to severe vision problems due to
cytokine production, fibroblast activation, and glycosaminoglycan deposition that cause vascular congestion and
tissue edema. Insulin-like growth factor 1 (IGF1R) plays a key role in TED's development, impacting endothelial
cell migration, fibrosis, and neovascularization; thus, TED patients can be prescribed teprotumumab, an IGF1R
inhibitor. However, there is no standardized diagnostic or therapeutic tool for TED, making it crucial to develop
rapid imaging methods and quantifiable biomarkers to offer personalized patient care. Spatial Frequency Domain
Imaging (SFDI), developed at UCI's Beckman Laser Institute (BLI), is a promising solution. SFDI uses several
wavelengths to assess tissue properties (oxy and deoxyhemoglobin, oxygen saturation, as well as absorption
and reduced scattering coefficients) up to 5 mm in depth. SFDI has successfully predicted surgical outcomes
and treatment responses in other medical conditions.
Dr. Ediriwickrema’s research aims are to use SFDI to non-invasively identify optical tissue properties in
TED, particularly those related to vascular congestion and tissue edema (Aim 2A), as compared to age-matched
controls (Aim 1). She will also establish an optical signature profile for TED patients receiving teprotumumab
(Aim 2B). The team will also conduct clinical pathology correlations (CPC 1, 2A, 2B) on surgical specimens from
both healthy and TED patients.
This K23 proposal provides comprehensive training for Dr. Ediriwickrema and enables her to develop
noninvasive diagnostic and therapeutic response metrics for TED and similar inflammatory conditions. Dr.
Bernard Choi, a recognized expert in wide-field imaging applications in the characterization and treatment of
microvascular-related diseases, will mentor Dr. Ediriwickrema. Secondary mentors, Drs. Anthony Durkin, Anand
Ganesan, Krzysztof Palczewski, and Kristen Kelly bring extensive expertise in the development and application
of in vivo SFDI techniques, multiphoton microscopy for assessing cutaneous inflammatory changes, and
advanced high-resolution molecular imaging techniques, such as 2-photon imaging. Additionally, Drs. Vivek
Patel, Vasan Venugopalan, and Maria Estopinal will provide valuable guidance in TED management,
optimization of SFDI-derived tissue optical parameters, and histopathologic evaluation of periocular inflammatory
disease. Dr. Ediriwickrema will benefit from the rich scientific environment at UCI, including resources in the
Department of Ophthalmology, BLIMC, Institute for Clinical and Translational Science (ICTS), Center for
Translational Vision Research (CTVR), and Biostatistics Epidemiology and Research Design (BERD) Unit. This
K23 training will equip Dr. Ediriwickrema with the skills to apply SFDI effectively to establish objective and
continuous optical tissue biomarkers that characterize TED activity and response to treatment, and enable her
to become an independent physician-scientist specializing in oculofacial inflammatory diseases.

Public health relevance
PROJECT NARRATIVE Thyroid eye disease affects approximately 0.1% of the United States population, yet there is currently no standardized approach for diagnosis, longitudinal monitoring, and therapeutic decision-making in this condition. This project utilizes spatial frequency domain imaging to examine tissue volumes within the periocular region of patients with thyroid eye disease to establish objective and continuous optical biomarkers of disease activity. These findings will provide valuable insights for developing metrics to assess therapeutic response, and potentially uncover novel therapeutic targets for inflammatory oculofacial disease.